Exploring knowledge gaps in childhood caries through integrated biological and clinical research

Project Summary/Abstract
Dental caries, the most common, chronic, infectious childhood disease, has a substantial impact on children’s
quality of life. The high prevalence of dental caries that persists despite its preventability necessitates
improvement in diagnostics and therapeutic interventions for this young and vulnerable population. Over the
years, significant progress has been made in caries research. Despite these advances, research gaps remain,
limiting the ability to answer two fundamental questions: 1) Why do not all individuals with elevated levels of
Streptococcus mutans (Sm), an important infectious, cariogenic bacterium, develop caries? 2) How does host
genetic variation contribute to the susceptibility to dental caries? The former continues to be a major enigma in
the field of oral microbiology. Though host susceptibility has been recognized as an important determinant in
medical infectious diseases, it remains an under-studied factor in caries research. Dr. Nini Tran, an Assistant
Professor at the UCLA School of Dentistry, is a pediatric dentist-scientist with a well-rounded training and a
long-standing commitment to a research career. The career development plan enables Dr. Tran to gain
additional expertise in three areas: 1) Microbiology and microbiome research, 2) biostatistics and
bioinformatics, 3) saliva diagnostics. Dr. Tran will be supported by an outstanding multidisciplinary mentoring
team with expertise to cover all elements of her research and career development. Dr. David Wong, a pioneer
in the field of saliva diagnostics, is her primary mentor; Dr. Wenyuan Shi, Dr. Jeff Miller, Dr. Renate Lux, Dr.
Xuesong He, Dr. Floyd Dewhirst, and Dr. Ann Griffen are the leading microbiology and microbiome experts; Dr.
David Elashoff provides biostatistics support, while Dr. Jeff McLean has expertise in next-generation
sequencing and bioinformatics analyses. Through a tailored curriculum of courses, workshops and the
proposed research, Dr. Tran will develop crucial skills to achieve her goal of becoming a successful
independent clinician-scientist in the field of childhood caries diagnostics and therapeutics. This research
investigates a discordant, preschool child population whose caries status contradicts what is expected based
on their Sm level in comparison to the accordance counterpart. Integrating innovative study design and novel
tools, the research plan aims to 1) characterize Sm strain individuality and its ecological relationship within
different microbial communities, 2) explore salivary host biomarkers related to childhood caries, and 3) validate
Sm-associated microbial virulence signatures and host salivary biomarkers for precise and comprehensive
caries assessment. This research will generate the basis for R01 proposals, focusing on oral microbiome inter-
species interaction, and host and oral microbial interaction related to childhood caries susceptibility, and the
development of diagnostics and therapeutics for childhood caries. Finally, this award will position Dr. Tran to
become a top tier pediatric dentist-scientist, and enable her to make a significant contribution to the field of
pediatric dentistry.

Public health relevance
Project Narrative ! Dental caries, though preventable, is the most common, chronic infectious childhood disease with substantial impact on children’s quality of life. With innovative study design and novel tools, this proposal aims to uncover knowledge gaps in microbiology and host susceptibility of childhood dental caries. Findings from this research will give insight into why certain children are more susceptible or resistant to dental caries and potentially lead to the development of a saliva-based diagnostic tool using the identified microbial and host genetic markers.